Quantifying Exposure to Illicit Drugs & Psychosocial Stress in Real Time

Assessment of exposure to drug use and psychosocial stress is complicated by the fact that each is often transient and difficult to recall accurately. Assessment of their causal connections with one another, and of their genetic and environmental determinants, is complicated by the complexity of the causal connections and by the elusive nature of what constitutes the environment. In this study, we are assessing drug use and psychosocial stress in near-real time through Ecological Momentary Assessment (EMA), in which participants use handheld electronic diaries to record events as they occur and to report recent or ongoing events in response to randomly timed prompts throughout the day. We are also maintaining real-time records of where the reported events occurred by having participants carry Global Positioning System (GPS) devices to track their whereabouts with a spatial resolution of several meters. Broadening the definition of environmental factors, we are evaluating neighborhood-level exposures to drugs and stress measured in terms of specially developed indices, the Drug Environment Index (DEI) and the Neighborhood Psychosocial Hazards index (NPH), each based on objective statistical data available from public sources and independent of self-report, plus the NifETy index, based on objective environmental ratings by trained observers. For comparison, drug exposure will also be assessed through retrospective interviews and from biological specimens (sweat), and stress will be assessed through physiological measures (heart rate and allostatic load). The project represents a collaboration between the NIDA IRP (where we have are already published EMA data from polydrug-dependent outpatients) and Johns Hopkins ALIVE Study investigators (following a well-characterized community cohort of drug abusers, most of whom are not in treatment). After developmental work at NIDA linked to field trials in ALIVE, the result is expected to be a set of field-deployable, state-of-the-art tools indispensable to future studies of gene-environment interactions affecting drug use and stress. In the past year, we successfully ran a pilot study in which we collected both EMA and location data. We have just initiated a larger trial incorporating additional stress measures.